The OSU Center for Clinical and Translational Science: Advancing Today's Discoveries to Improve Health

ABTRACT
The Ohio State University (OSU) Center for Clinical and Translational Science (CCTS) was formed in 2007,
with the vision to advance today’s discoveries to improve health for all. We employed a comprehensive
approach to address the full spectrum of T1-T4 science via the education and career development of a highly
trained workforce integrated with a robust system of CTR resources. We provided leadership in the CTSA
Consortium through sharing of tools and methods to advance CTR; adopted innovations from other hubs; and
fully engaged in CTSA Consortium activities (e.g., multisite trials). We also supported community engaged
research addressing the most pressing health issues in our communities (e.g., opioid crisis, COVID-19). Yet,
work remains. Thus, we build upon unique strengths at OSU/NCH and in Ohio’s communities. We have
leveraged our strategic investment in data sciences, a robust environment of resources, and a vibrant CTR
community to address CTS gaps and barriers. We will now address five CTS roadblocks to improve the
quality, efficiency, and rigor of CTR: (1) need for improved efficiencies and effectiveness to advance CTR and
ensure results are disseminated and implemented into healthcare; 2) education and training innovations do not
reach the full CTR workforce, resulting in a declining and inadequately diverse CTS workforce, lacking the
knowledge and skills to advance CTR; 3) limited authentic participation by diverse stakeholders across the
research life cycle; 4) growth of complex datasets necessitates integration of clinical, environmental, and
research data, with need for democratization of data accessibility to advance data equity; and 5) racial injustice,
SDoH, the CTR teams we form, and interpretation of our results impact health disparities. Applying a health
equity and DEIA framework to every activity, we will pursue five aims: Aim 1: Develop innovations in
methods, approaches, and tools to address pressing roadblocks facing CTR. Aim 2: Support training and
career development of the full CTS workforce. Aim 3: Engage voices from across academic and scientific
disciplines, patients, communities, and industry to conduct CTR and CTS across the full lifecycle of the scientific
process. Aim 4: Deploy an accessible, responsive, and integrated system of research resources. Aim 5:
Democratize informatics resources by lowering the cost of entry for data access and computing resources. With
a commitment to metric-driven decision-making, we will evaluate the impact of the CCTS by applying the RE-
AIM framework to inform strategic pivots over the next 7 years. This proposal reaffirms our commitment to
advance CTS and expands our engagement with stakeholders to increase rigorous, impactful, and relevant
CTR. We will develop, share, and adopt innovations through focused CTS to enhance CTR for the communities
we serve and those we engage. These resources, skilled workforce, and institutional strengths provide an agile
foundation to facilitate rapid responses to emerging public health issues, and will ensure an equity lens is
applied to all CTR so no one is left behind from the advances of CTR to improve human health.

Public health relevance
PROJECT NARRATIVE This Clinical and Translational Science Award (CTSA) will continue support for the The Ohio State University (OSU) Center for Clinical and Translational Science (CCTS) in partnership with Nationwide Children’s Hospital. Applying a health equity and DEIA lens to everything we do, we will address critical clinical translational roadblocks to provide leadership, education, training, and resources, in collaboration with the CTSA Consortium, to advance today’s discoveries and improve health for all.